Erythrocyte maturation through global remodeling of the proteome

PROJECT SUMMARY / ABSTRACT
As cells undergo extreme forms of terminal differentiation, they are able to accumulate specific proteins
to exceptionally high levels–hundreds of milligrams per ml in the case of globins and crystallins. At the same
time, almost all other cellular components are eliminated. How cells can carry out such vast programs of
biosynthesis and degradation simultaneously has been almost a complete mystery. We proposed in 1995 that
the ubiquitin-proteasome system (UPS) may play a central role in global proteome remodeling. Using murine
reticulocytes, a uniquely powerful system to study global proteome remodeling, we found that indeed UBE2O, a
ubiquitin-conjugating enzyme that is strongly induced in late erythroid differentiation, mediates the elimination of
ribosomes and myriad other proteins via the proteasome. We proceeded to examine other UPS components
that are strongly induced in erythroid cells, and found that TRIM10 eliminates dynactin, many myosins, actin
crosslinking proteins, the erythroid regulator TMCC2, and COP1 vesicles; TRIM58 eliminates dynein and
centrosomal proteins; the unique ubiquitin-like protein TBCEL specifically dismantles the tubulin cytoskeleton;
and UBE2H, together with the GID complex, eliminates a broad set of mRNA-binding translational regulatory
proteins while also promoting the elimination of many mitochondrial proteins. Thus, these UPS components have
highly distinct specificities, each driving the elimination of different parts of the cell or proteome. This work
uncovers a vast new regulatory pathway that appears to be central to the maturation of the erythrocyte. It also
indicates a remarkable new capacity of the UPS: to effect global and developmentally controlled proteomic
remodeling. In contrast to the above-described proteins, most UPS components disappear during erythroid
maturation; thus, a highly specialized variant of the UPS mediates remodeling. Focusing on TBCEL, TRIM10,
and TRIM58, we will use biochemical reconstitution, crystallography, and hydrogen exchange mass
spectrometry to resolve specific mechanisms of degradation and degradation signals in target proteins. Cellular
studies will focus on the cytoskeleton and on translational control as highlighted by our proteomic data. As the
erythroblast matures into the red blood cell, its radial, microtubule-based cytoskeleton is replaced by an acentric
actin-based network. We will characterize how the cytoskeleton functions during the unusual and to date
uncharacterized transition period that takes place in the reticulocyte. We will then assess the impact of
programmed elimination of tubulin and other cytoskeletal proteins on this cytoskeletal transformation. Although
late erythroid cells are known to be characterized by extensive translational regulation, our findings indicate a
new mechanism by which diverse translational regulators are themselves controlled. We will use our mutants to
determine the impact of UBE2H-dependent ubiquitination on mRNA translation in reticulocytes, using RNA-Seq
and Ribo-Seq in parallel. In summary, we propose that ubiquitin-dependent proteome remodeling is an important
new aspect of the biology of eukaryotic cells, critical for the generation of highly differentiated cell types.

Public health relevance
PROJECT NARRATIVE Red blood cells are generated through a process of extreme terminal differentiation, whereby thousands of proteins are lost from the cell and replaced primarily by hemoglobin, which eventually constitutes ~98% of soluble protein. It has been a mystery how so many proteins could be eliminated from cells while specific proteins such as hemoglobin are preserved, but our recent work has implicated the protein modifier ubiquitin in this process, and in the proposed studies we will map this novel biological process by applying quantitative global proteomics and biochemical analysis to numerous mutants of ubiquitinating enzymes that are specifically induced in the late phase of red blood cell differentiation. These studies are providing a fundamental new perspective on cellular differentiation.